Center for Neurorestoration and Neurotechnology

The VA RR&D Center for Neurorestoration and Neurotechnology (CfNN) at the Providence VA Medical
Center (PVAMC) unifies a distinguished team of scientists, engineers and clinicians from the VA, Brown
University, and affiliated hospitals to develop and translate neurotechnologies and device-­based therapies
that restore function for Veterans with disorders affecting the nervous system. CfNN’s three Focus Areas are
each dedicated to performing the rigorous, peer-­reviewed science that leads to new diagnostic and
therapeutic strategies for Veterans with spinal cord injury, stroke, amyotrophic lateral sclerosis (ALS),
epilepsy, limb loss, post-­traumatic stress disorder (PTSD), depression, chronic pain, and other nervous
system diseases or injuries. CfNN’s three Focus Areas are: (1) Restoring Communication and Mobility (2)
Restoring Affective and Cognitive Health, and (3) Restoring Limb Function. The Focus Areas’ interdisciplinary
research efforts are supported by three Cores providing essential infrastructure support and specialized
services: (A) Neuromodulation and Neuroimaging (B) Recording, Decoding, and Computational
Neuroscience, and (C) Assessment, Outcome Measurement, and Implementation. CfNN research is further
facilitated by a dedicated administrative staff who support scientific productivity, coordinate the synergistic
relationships between CfNN and its academic and clinical affiliates, maintain close contact with local and
national VA officials, and optimize our service to Veterans. CfNN’s research strategy maximizes interactions
via complementary expertise and resources among its Focus Areas and Cores. This in turn supports a high-­
impact research community focused on application of medical devices to neurologic health, both within the
VA and in the wider regional and national brain science community. Through this renewal, over the next five
years CfNN will leverage and expand its collaborative research, both within the Providence VAMC and
together with other VA Centers, toward rehabilitation goals important to the large number of affected
Veterans and their families. These include: restoring arm and leg movement for Veterans with stroke, spinal
cord injury, or amputation;; improving communication for Veterans with ALS;; improving the understanding,
early detection, and management of seizures, and;; more successfully treating Veterans with PTSD,
depression, obsessive-­compulsive disorder, or other severe cognitive or affective disorders. CfNN also aims
to develop and validate the outcomes measures needed for effective clinical trials of new restorative
neurotechnologies for these conditions. In addition to the research of its core investigators, CfNN is designed
to facilitate the training and research careers of junior researchers and to recruit established clinicians and
scientists to focus their research efforts on improving rehabilitation for Veterans with nervous system disease
or injury. CfNN is committed to providing seed funding for pilot studies to enable affiliated investigators to
launch promising research and collect preliminary data to inform and strengthen larger research projects.
Through its close association with Brown University, CfNN provides educational opportunities to
undergraduates, graduate students, neuropsychology interns, and postdoctoral researchers to learn more
about the VA, inspiring them to shape their careers toward not only gaining a better understanding of
fundamental human neuroscience, but toward using that knowledge to help design, test, and deploy novel
device-­based neurotherapeutics to support Veterans Health.

Public health relevance
Disorders of the brain and nervous system, including those resulting directly from injuries incurred during military service, are of immediate relevance to Veterans health. In part because of the complexity of the nervous system, people who have disorders such as stroke, spinal cord injury, limb loss, amyotrophic lateral sclerosis, post-traumatic stress disorder, or chronic pain lack adequate rehabilitation therapies to regain their independence. Through rigorous translational and clinical research conducted by a multi-disciplinary team of scientists, engineers, and clinicians, the VA RR&D Center for Neurorestoration and Neurotechnology develops and tests novel device-based approaches to improving the health and lives of Veterans. An explicit goal of the Center is to translate neurotechnology and its applications into clinical practice in service to our Veterans and civilians throughout the US.